Cholinergic influence on visual cognitive processing

PROJECT SUMMARY/ABSTRACT
Impairment in visual attention and working memory is common across mental illnesses and neurological
conditions. Cholinergic drugs (acetylcholine agonists and acetylcholinesterase inhibitors) can ameliorate these
symptoms, though their effectiveness is limited. An alternative way of improving cholinergic function is to
stimulate the endogenous source of acetylcholine in the cerebral cortex, the Nucleus Basalis of Meynert. Recent
results have shown the effectiveness of the approach in improving performance in working memory and attention
tasks. However, the neuronal mechanisms of action in cortical areas involved in these processes are not yet
understood. This project will investigate the effects of Nucleus Basalis stimulation on the activity of neurons in
the dorsolateral prefrontal and posterior parietal cortex, as monkeys are performing visual working memory
tasks. Neurophysiological recordings will be performed before, during, and after Nucleus Basalis stimulation.
Our overarching hypothesis is that Nucleus Basalis stimulation broadens the tuning of prefrontal cortical neurons,
which results in better stability of working memory representations, at the expense of accuracy for some
conditions. We hypothesize that this effect generalizes to the posterior parietal cortex, as well. We will also
determine the effects of stimulation on other aspects of neuronal firing and whether alternate mechanisms can
account for behavioral effects of stimulation. Both acute effects of stimulation, in daily sessions, and sustained
effects over a period of months, will be assessed. Systemic administration of cholinergic agents will also be
performed and its effects on neural activity will be compared with those of Nucleus Basalis stimulation. The
experiments will allow us to understand the effects of cholinergic transmission associated with performance of
visual cognitive tasks. They will also evaluate the relative effectiveness of drug administration compared to deep
brain stimulation. Our research will also provide a primate model for the evaluation of an intervention that can
potentially improve cognitive function across a range of mental illnesses and neurological conditions.

Public health relevance
PROJECT NARRATIVE Diminished levels of the neurotransmitter acetylcholine in the brain have been implicated in cognitive impairments associated with mental illnesses and neurological conditions. The proposed research will determine the effectiveness of deep brain stimulation as a means of boosting acetylcholine levels in brain areas critical for higher cognitive functions, the prefrontal and posterior parietal cortex, and improving cognitive function.